EFFECT OF PROLONGED HYPERGLYCEMIA

The investigators plan to test the hypothesis that prolonged (up to 72 h) hyperglycemia per se may activate blood coagulation and platelet sensitivity and in addition may decrease fibrinolysis.